Abdominal Pain in Older Patients in Emergency Departments

PROJECT SUMMARY/ABSTRACT
Candidate: Ari B. Friedman, MD, PhD is junior faculty at the University of Pennsylvania (Penn). He practices
clinically as an emergency physician and conducts research as a health economist into how care systems
affect patients' lives. He is passionate about improving the care and outcomes of the many older patients that
he sees in the emergency department (ED) by improving the science underlying that care.
Goal: The purpose of this K23 Career Development Award is to enable Dr. Friedman to gain knowledge and
skills necessary to become an independent investigator focusing on the emergent care of older patients.
Research Context: Visits to hospital EDs are a growing source of care for adults over 65, totaling 22.4 million
visits in 2017. Among older patients, abdominal pain is the single most common chief complaint. Simply being
over 65 years, presenting to an ED, and stating at triage, “I have abdominal pain,” as a chief complaint confers
a mortality rate as high or higher than an ST-Elevation Myocardial Infarction (STEMI), with equivalently high
morbidity. Yet little is known about this phenomenon, especially for patients with frailty or cognitive impairment.
Career Development Plan: Dr. Friedman seeks training in frailty, cognitive impairment and dementia,
geriatrics, primary data collection, and health disparities. This award will provide protected time for Dr.
Friedman to acquire the skills necessary to secure independent funding through a progressive, milestone-
driven training plan that includes coursework, mentored research, and guided independent study.
Aims: The central hypothesis of this proposal is that there are identifiable ways to improve the evaluation and
management of abdominal pain among older patients in the ED. Dr. Friedman will use the training funded by
this Mentored Patient-Oriented Research Career Development Award to examine variation in ED abdominal
pain testing, management, disposition, and outcomes overall and among patients with frailty, cognitive
impairment, among disadvantaged populations, and in periods when resources do not meet demand.
Research Plan: These Aims will be carried out by using primary data collected through the proposed ED
Geriatric Abdominal Pain (ED-GAP) cohort with additional variables from the Penn Electronic Health Record
(EHR). This data will capture both management and outcomes for admitted patients and contains
measurements of essential factors associated with aging. Retrospective EHR data of abdominal pain visits to 6
EDs over 8 years will also be used. Multivariate regression will test the hypotheses above.
Environment: Senior researchers with an established track record of mentoring scholars from their early
career to independent and impactful work are committed to Dr. Friedman's success. This team is embedded
within a university environment with a track record of collaborative, pathbreaking scholarship in health
economics, health services research, emergency medicine, and gerontology.

Public health relevance
Abdominal pain in patients over 65 years old is very common, causing 1.4 million emergency department visits per year. Older adults who develop abdominal pain severe enough to seek care at an emergency department have poor health outcomes, including death, as often as patients who develop a heart attack. This proposal seeks to understand how care of this patient population is managed—especially for patients with impaired cognition, Alzheimer's disease and related dementias, and/or frailty—so that it can ultimately be understood and improved.